Addressing cancer disparities in Nigeria through Immuno-oncology Research – The NOLA Program

PROJECT SUMMARY – OVERALL
In the US and other high-income countries, immunotherapy is transforming the management of some cancers,
including colorectal cancer (CRC). However, immunotherapy is not widely available to patients in low- and
middle-income countries (LMICs) who might benefit the most. Our collaborations in sub-Saharan Africa over the
past 10 years have highlighted disparities for Nigerian patients diagnosed with CRC – 53% of Nigerian CRC
patients will die within a year of diagnosis, compared to 17% in the US – and incidence in Nigeria is rising.
Interestingly, in work to understand the biological underpinnings of these disparities, we found a 3-fold higher
rate of the immunogenic MSI-H (high microsatellite instability) phenotype in Nigerian compared to US CRC,
suggesting a unique opportunity to address CRC disparities in Nigeria with immunotherapy. Based on these
findings, we are separately initiating the first prospective trial of immunotherapy for MSI-H CRC in sub-Saharan
Africa. While promising, our work in this area has illuminated the severe lack of immuno-oncology data from
Nigerian patients (and other LMIC populations) at all scientific levels. Bringing the promise of immunotherapy to
these populations requires a contextual understanding of CRC immunobiology, biomarkers to efficiently and
cost-effectively select patients most likely to benefit from treatment, and regional immuno-oncology experts with
knowledge of immunotherapy and immune-related side effects. To address these needs, we will establish the
Nigerian Immuno-Oncology Research (NOLA) program, with a goal to synergize our existing strengths in global
cancer disparities research and immuno-oncology that have, until now, lacked an integrated focus and
coordination. Specifically, in this P20 project, we will unite a multi-disciplinary group to 1. develop pilot data to
guide future studies investigating the tumor microenvironment of Nigerian CRC; 2. integrate a multi-disciplinary
team and research projects focused on immuno-oncology in Nigerian and US cancer patients; and 3. develop
biobanks and databases of Nigerian CRC to support future immuno-oncology research. By the end of the project
period, we will have generated the preliminary data, resources, infrastructure, and program plan to support a
robust multi-disciplinary, collaborative immuno-oncology research to address health disparities between Nigerian
and US patients with CRC beyond the P20.

Public health relevance
NARRATIVE – OVERALL Compared to patients in the US, Nigerian patients present with colorectal cancer at a younger age and with more advanced disease and worse survival. While the reasons for these disparities are multi-factorial, our NIH-funded studies suggest unique biology and a potential role for immunotherapy in improving outcomes. The Nigerian Immuno-Oncology Research (NOLA) program will synergize our existing strengths in global cancer disparities research and immuno-oncology to address clinically meaningful questions regarding colorectal cancer immunobiology and clinical care of patients with immunotherapy in Nigeria, and how these factors can be leveraged to address colorectal cancer disparities.